Non-cytotoxic augmentation of fetal hemoglobin and bone marrow reserves

ABSTRACT
SCD patients require erythropoiesis >10-fold over normal to barely sustain hemoglobin levels compatible with
life, and dwindling compensatory capacity is a major cause of early death. Therefore, our overall goal in Project
3 is to develop methods of inducing HbF that are non-cytotoxic and preserve or even increase marrow reserves.
Biologically undergirding our approach is the `maturational switch': the switch of the shared enhancer from γ-
globin (HBG) to the adult β-globin gene (HBB) during non-fetal erythropoiesis, a switch that first requires
acquisition of repressive marks at HBG. As examined in Project 1, the repressive marks are catalyzed by
druggable enzymes, e.g. DNMT1, and inhibiting these enzymes favors the LCR interaction with HBG, producing
significant HbF increases even in patients with severe, HU-refractory SCD. Moreover, as examined in Project
2, treatments that retard erythroid maturation can potentially widen the maturation-stage window for inhibition of
repressing enzymes, enabling greater HbF inductions while simultaneously increasing RBC output per
progenitor, relieving some of the demands on dwindling and precious marrow stem cell reserve. This highly
innovative but rational concept is evaluated clinically for the first time in Aim 1, by combining nicotinamide (vit.B3),
which retards hematopoietic maturation but not proliferation, is very well-tolerated, and is a major mediator of
the benefits of glutamine supplementation in SCD, with THU-decitabine, a novel orally bioavailable non-cytotoxic
drug that targets DNMT1. Aim 2 addresses a more obvious concept, that although any HbF induction is
potentially beneficial, achieving maximum protection with HbF ~30% may require combining inhibitors of
individual HBG repressing enzymes. The culmination of chromatin remodeling for repression is nucleosome
repositioning that physically denies access to the basal transcription machinery. This energetically expensive
work is executed by ISWI family enzymes, e.g., CHD4 (Project 1). CHD4 inhibition should hence offer
corresponding potency for HbF induction. We have therefore screened for and optimized through structure-aided
design a first-in-class CHD4 inhibitor - we will evaluate this inhibitor for HbF inducing potency and drive toward
IND-enabling. Aim 1: Conduct a proof-of-concept study of oral nicotinamide (vitamin B3) and oral THU-
decitabine, alone and in combination, to treat severe SCD. This proof-of-concept study of combination non-
cytotoxic oral therapy to both induce HbF and augment bone marrow reserves will randomize adult SCD patients
at risk of early death to nicotinamide or oral THU-decitabine alone. Aim 2: Determine the HbF inducing
potency of small molecule CHD4 inhibition in vitro and in vivo, to justify IND-enabling studies. We will
employ primary cell ex vivo systems to compare the HbF inducing potency of the novel drug vs established
agents, followed by evaluation in SCD mice (Project 1), and finally in non-human primate models (Project 2).
Hence, candidate molecular targets for simultaneous induction of HbF and augmentation of bone marrow
reserve, identified and validated in Projects 1 & 2, are translated into or toward the clinic by Project 3.